Characterize Merging HIV Strains from Blood Donors and Patients

The purpose of this agreement is to continue research at the FDA lab on HIV characterization studies for NIAID’s efforts to develop a well-characterized, dynamic repository of diverse HIV strains for diagnostics, drug and vaccine studies. To accomplish this, CBER and NIAID will collaborate in the work of characterizing these diverse strains and using a subset of viruses and plasma to develop globally diverse panels for evaluating performance of HIV diagnostic assays.